Statistical Data Enclave

Core E encompasses several specific activities aimed at the general goal of improving access for researchers to confidential and sensitive data and ensuring the confidentiality of survey respondents. 1. To maintain and expand the secure data enclave located in the Institute for Social Research. Currently the enclave is focused mainly on the Health and Retirement Study and files linked to it. We propose to develop partnerships with other producers and custodians of sensitive data, including the Panel Study of Income Dynamics, NCHS, the U.S. Census Bureau, and the Institute for Employment Research (lAB) of the German Federal Employment Agency (BA), to expand the availability of restricted datasets;and the exploration of technologies for secure remote access to enclave data. 2. To provide outreach to other NIA Aging Centers to develop best practice standards for, and encourage and assist in the establishment of, other enclaves. 3. To explore legal issues and institutional solutions posed by HIPAA legislation and other regulations affecting privacy and use of statistical data in research. 4. To promote research designed to address statistical and other issues related to the maintenance of confidentiality while increasing the accessibility of microdata.

Public health relevance
The data enclave makes it possible to preserve confidentiality while conducting exciting new research that integrates biomedical data with traditional survey data, and links survey data to geographic and administrative databases. Such research includes neighborhood effects on health, health of immigrants by place of origin, migration and health, and analyses of SSDI and SSA data that control for local characteristics. The enclave also allows foreign-based researchers to access restricted HRS data.